Metabolism and Epigenetic Regulation are Couples in Transdifferentiation and Vascular Regeneration

Abstract
We discovered that nuclear reprogramming of somatic cells to a different somatic cell lineage, or
induced pluripotent stem cells, requires activation of inflammatory signaling within the cell. Specifically,
pattern recognition receptors (PRRs) such as toll-like receptors (TLRs) mediate a cell-autonomous
innate immune response via NFKb and IRF3. We found that this inflammatory signaling causes global
changes in the expression and/or activity of epigenetic modifiers to increase DNA accessibility and
fluidity of cell phenotype. Subsequent work has suggested that this process of “transflammation” may
be involved in vascular regeneration. Specifically, we have shown that fibroblasts in an ischemic region
can be transformed into endothelial cells (ECs) through an “angiogenic transdifferentiation” process.
This process contributes to the recovery of perfusion in the ischemic region, as the recovery of the
microvasculature, and the restoration of blood flow in an ischemic region is antagonized by factors
required for angiogenic transdifferentiation (e.g., inflammatory signaling). My recent work indicates that
cell metabolism may be an important contributor to this process. Specifically, a glycolytic shift is
induced by inflammatory signaling which is required for the transdifferentiation of fibroblasts to ECs.
Thus, regulating cell metabolism within fibroblasts to facilitate their transdifferentiation into reparative
ECs may be a novel strategy for treating ischemia. To determine the molecular metabolic pathway that
leads to transdifferentiation, we will alter the function of key metabolic enzymes in mice
pharmacologically and genetically in vivo to confirm our proposed pathway and demonstrate the
metabolic regulation of transdifferentiation in a mouse model of peripheral artery disease (PAD). We
will pursue experiments to trace key metabolites and demonstrate their importance in mediating DNA
accessibility and transdifferentiation to identify their role in epigenetic regulation in cell fate transition.
Completion of these studies will demonstrate the novel concept that metabolic regulation within cells
contributes to their fate and provide novel targets to enhance this process for the treatment of PAD.

Public health relevance
Our laboratory has identified a role for glycolysis in transflammation and studies proposed here will characterize the dependency of acetyl-CoA metabolism on innate immune activation and identify the epigenetic effects of acetyl-CoA during transdifferentiation in vivo. Further, we will confirm the role of glycolysis in transdifferentiation using an established mouse model of peripheral artery disease. Completion of these studies will provide a novel pathway utilized by cells undergoing fate determination.